PROVIDE SUPPORT SERVICES FOR THREE NATIONAL INFORMATION

Under this contract, the Contractor will provide logistical and administrative services in support of the activities of three (3) congressionally mandated national information clearinghouses: the National Diabetes Information Clearinghouse, the National Digestive Diseases Information Clearinghouse, and the National Kidney and Urologic Diseases Information Clearinghouse.